UAB NORC Core D: Behavioral Science and Analytics

PROJECT SUMMARY – BEHAVIORAL SCIENCE AND ANALYTICS CORE
The UAB NORC Behavioral Science and Analytics Core fulfills the need among nutrition and
obesity researchers for guidance in developing study designs, consultation for statistical analysis,
and development of new statistical methods to answer the unique questions posed by NORC
investigators. It also provides consultation and assistance with behavioral techniques to support
the development and delivery of behavioral and other clinical interventions for nutrition- and
obesity-related conditions. We will guide investigators in the selection of theoretically-grounded
and empirically-informed interventions; assist with decisions related to intervention dose,
modality, and content; and offer resources and staff to deliver selected interventions. The core
also supports the selection and implementation of study designs to evaluate behavioral constructs
and outcomes in nutrition/obesity research. We will provide consultation and support in
developing obesity-related behavioral studies and assist with the selection of study design,
including quantitative, qualitative, and mixed methods; sample size estimation; and choice of
behavioral assessments using quantitative and qualitative methods. The core provides electronic
data capture and data management support for nutrition/obesity studies. We will assist in
implementing data capture systems for trials and observational studies, which would include
setting up electronic case report forms, integrated implementation of randomization techniques
including minimization, and integration of wearable and remote data collection technologies such
as integrated voice response and text message for remote collection of behavioral data. Finally,
the core provides data analyses consultation and support for behavioral studies related to
nutrition/obesity.